Investigating the Genetic Basis of Metabolic Disease and Familial Dysceramidemia in Pacific Islanders

PROJECT SUMMARY
Pacific Islanders (PIs) have among the world’s highest burden of metabolic disease and are at increased
risk for other associated comorbidities, such as cardiovascular disease, kidney disease, and cancer. Despite
high rates of these complex diseases, PIs have largely been underrepresented in studies designed to identify
the underlying factors that contribute to their increased risk. Ceramides are lipotoxic sphingolipids that
contribute to cellular dysfunction that cause metabolic disease. While much of the literature implicating
ceramides in metabolic disease has centered on genetic modification or pharmacological inhibition of genes
involved in ceramide synthesis pathways in various model systems, accumulation of ceramides has also been
demonstrated in human disease. The underlying mechanisms leading to increased ceramides in human
disease, however, are unknown. As part of our studies leveraging unique resources at the University of Utah,
including the Utah Diabetes Database and the Utah Population Database, we recently identified rare mutations
that alter ceramide levels in 2 families enriched for obesity, diabetes, and end-stage renal disease, causing
familial dysceramidemia, including the first family from the Pacific Islands with a rare genetic variant associated
with elevated ceramides. Given this novel and important finding, we hypothesize that aberrant sphingolipid
levels and genetic variants that alter their biosynthesis are key contributors to metabolic disease and related
comorbidities in PIs. Building on this evidence, the goal of this developmental research project is to expand
this research and investigate the role of sphingolipid levels in metabolic disease in PIs using a multi-omics
approach that includes lipidomic and genomic analysis of large, multi-generational PI pedigrees. To
accomplish this goal, we will 1) determine sphingolipid levels in members of 25 large, multi-generational PI
pedigrees with metabolic disease by i) expanding recruitment of PI families currently enrolled in the Utah
Diabetes and Diabetic Complications Study to include at least 10-15 members per family and ii) use liquid
chromatography with tandem mass spectrometry to establish lipid profiles of sphingolipid species in all recruited
PI family members and 2) evaluate the contribution of genetic variation on sphingolipid levels in members of
large, multi-generational PI pedigrees by i) screening for genetic variants in members of PI families with aberrant
sphingolipid profiles using whole exome sequencing and ii) performing unified linkage analysis and rare variant
association testing to identify variants influencing sphingolipid species. We anticipate that this research will
build on exciting preliminary data and provide key insights on the role of this pathway in metabolic disease in
PIs. This research will provide a solid foundation for future efforts aimed at elucidating the mechanisms behind
the disparity of metabolic disease in PIs and facilitate translation of these findings to improved diagnostics and
therapeutics.

Public health relevance
PROJECT NARRATIVE Pacific Islanders (PIs) have among the world’s highest burden of metabolic disease and are at increased risk for other associated comorbidities, however, they have largely been underrepresented in studies designed to identify the underlying factors that contribute to their increased risk. As part of our studies leveraging unique resources at the University of Utah, including the Utah Diabetes Database and the Utah Population Database, we recently identified rare mutations that alter ceramide levels in 2 families enriched for obesity, diabetes, and end-stage renal disease, causing familial dysceramidemia, including the first family from the Pacific Islands with a rare genetic variant associated with elevated ceramides, implicating this pathway as a key contributor to metabolic disease and related comorbidities in PIs. Building on this evidence, the goal of this developmental research project is to expand this research and investigate the role of sphingolipid levels in metabolic disease in PIs using a multi-omics approach that includes lipidomic and genomic analysis of large, multi-generational PI pedigrees.